The Texas Implementation Science Research Consultation Hub to End HIV

PROJECT ABSTRACT
The research-to-practice gap remains a significant barrier to ending the HIV epidemic (EHE). Despite major
advances in HIV/AIDS prevention, screening, diagnosis, and treatment, the implementation and sustainment of
game-changing tools like pre-exposure prophylaxis (PrEP) and the rapid initiation of antiretroviral therapy
(ART) continue to lag, particularly in resource-limited settings. The proposed Texas Implementation Science
Research Consultation Hub (TX IS Hub) to EHE will serve as a premier resource, providing implementation
science expertise in HIV/AIDS research, practice, and policy in Texas, neighboring Southern states, and
nationally. Our TX IS Hub can play a particularly important role in EHE research, practice, and policy as five
EHE priority jurisdictions (Bexar, Dallas, Harris, Tarrant, and Travis Counties) are in Texas. The impact of HIV
is exacerbated in Texas due to several factors: the state's decision not to expand Medicaid, its fragile
healthcare safety net, the highest rate of uninsured residents, and its prioritization of limited government
intervention. These issues are also prevalent in other Southern states like Florida, Georgia, Mississippi, and
Oklahoma, which face similar challenges in addressing the HIV epidemic. Therefore, there is an urgent need
for enhanced IS infrastructure to combat the HIV epidemic in Texas and the U.S. South, both to contribute to
EHE and to learn how to best do so in resource-constrained areas of the country by providing critical resources
and consultation on HIV/AIDS implementation research, practice, and policymaking. The TX IS Hub will play a
pivotal role in building cross-institutional research capacity locally and nationally. The Hub's leadership (MPI:
Bala, Rodriguez, Markham), comprising expert HIV/AIDS and implementation science investigators, aims to
achieve the following specific aims: 1) Synthesize and disseminate HIV-focused implementation science
knowledge to researchers and practitioners using multi-modal dissemination strategies; 2) Provide coaching
and technical assistance to local, regional, and national EHE researchers to incorporate rigorous
implementation science in research projects; 3) Build the implementation capacity of community and clinical
organizations focused on EHE in Texas; and 4) Collaborate with the Coordination, Consultation, and Data
Management Center in cross-hub activities such as data harmonization, planning, and evaluation. The
UTHealth Houston Institute for Implementation Science will serve as a central repository for the resources and
tools developed by the Hub, ensuring their continued availability and impact on national efforts to end the HIV
epidemic.

Public health relevance
PROJECT NARRATIVE The Texas Implementation Science Research Consultation Hub (TX IS Hub) aims to serve as a critical cross- institutional infrastructure for building capacity in HIV implementation research, practice, and policy to advance the translation of evidence-based HIV practice. Focusing on Texas and the broader Southern U.S., where unique structural and health disparities persist, the Hub will disseminate knowledge regionally and nationally by synthesizing and sharing implementation science knowledge, providing coaching and technical assistance, leading capacity-building activities, and collaborating with diverse organizations through cross-hub initiatives. The successful completion of this project will enhance knowledge and capacity in implementation science and HIV, ultimately accelerating the translation of evidence-based HIV prevention, treatment, and management and contributing to ending the HIV epidemic.